Mammalian circadian rhythms: from genes to mechanisms

PROJECT SUMMARY / ABSTRACT
Circadian clocks play fundamental roles in regulating essential cellular and physiological processes. The
mammalian clock is comprised of cell-autonomous oscillators orchestrated by the hypothalamic
suprachiasmatic nuclei (SCN) to perform tissue and systemic functions. More than a dozen core components
of the oscillator have been identified; however, significant knowledge gaps remain regarding regulatory
mechanisms/components and tissue-specific functions in the clock system. My previous research has provided
important insights into mammalian circadian rhythms. For example, I generated Per2::Luc reporter mice which
proved to be a powerful reagent ubiquitously employed in the clock field. We recently reported a second-
generation reporter mouse line, Per2::LucSV, and demonstrated a novel miRNA regulation of PER2
accumulation and a positive role of PER2 in its own transcription. Most relevant to the current MIRA
application, I have been interested in combining mouse forward genetic screening and mechanistic studies to
probe fundamental clock functions. Previously we reported the identification by mouse screening and
mechanistic dissection of two antagonistic E3 ligase, FBXL3 and FBXL21 in circadian period regulation. More
recently, we uncovered a GSK-3beta-FBXL21 regulatory cascade controlling rhythmic degradation of the
sarcomere protein TCAP and skeletal muscle function. Building on these prior studies, the current proposal
aims to determine tissue-specific circadian mechanisms of FBXL21 and to identify novel clock components
from a streamlined mouse screening. We will examine new targets and functions of FBXL21 in striated
muscles including skeletal and cardiac muscles, focusing on proteostasis and myogenic differentiation.
Leveraging expertise in mouse forward genetic screening, I recently performed a genetic screening for
dominant phenotypes using an efficient breeding/phenotyping scheme. Whole-exome sequencing and variant
analysis pinpointed a novel circadian mutant line with a lengthened circadian wheel-running period and age-
dependent neurodegeneration. We will identify this new genetic component of the clock and characterize the
underlying regulatory mechanisms. Overall, these studies promise to discover important mechanisms and
functions of circadian rhythms in mammals. I have established an integrative research capability combining
mouse genetics and phenotyping, biochemical/molecular/cellular studies, imaging methodologies, and omics
platforms, complemented by expertise from a broad network of collaborators. These together form an excellent
foundation for the proposed research. The ultimate goal is to understand how biological timing governs bodily
function and what we can do to safeguard our health by optimizing our natural clock.

Public health relevance
PROJECT NARRATIVE Relevance to public health: Circadian clocks are biological timers that govern physiology and behavior; however, the underlying regulatory mechanisms are not fully understood. Utilizing an integrative approach, the proposed research will reveal novel genetic regulators of circadian rhythms and decipher molecular and physiological mechanisms governing tissue physiology. The fundamental insights will advance our understanding of biological timing and may ultimately lead to novel chronotherapies against clock-related diseases.